Alzheimer's Disease Research Center

Alzheimer's Disease (AD), the most common cause of dementia in the elderly, affects over 4 million Americans, a number projected to grow in coming decades; current overall costs for their care exceeds $100 billion per year. Current treatment options at best provide only temporary stabilization. Failures of clinical trials in AD have led to a focus on intervening earlier, when there is less structural damage to the brain. Characterizing and intervening in pre-dementia stages of AD is a research imperative. The UCSD Alzheimer's Disease Research Center (ADRC) has contributed greatly to research progress in the past 30 years. To continue to facilitate and conduct research into the causes, treatment and prevention of AD and related disorders, overall aims of this renewal application, which has been revised in August 2015, are: 1) To support research efforts by maintaining resources that include cohorts of subjects with normal cognition, Mild Cognitive Impairment (MCI), AD and other dementias (particularly Lewy Body Disease); neuropathology tissue from well-characterized subjects; biological samples (DNA, plasma and CSF); MRI and other brain images; and to maintain a comprehensive database. This will be carried out by six well- integrated Cores: Administrative, Clinical, Hispanic Satellite, Pathology, Outreach/Recruitment/Education (ORE) and Data Management/Biostatistics. 2) To support 3 research Projects: i) Probing SORL1 Risk Factors with Human Induced Pluripotent Stem Cell Technology ii) Disease Mechanisms in Frontotemporal Dementia Linked to C9orf72 Expansion. iii) Genomic mosaicism underlying posterior cortical atrophy (PCA) [new project, part of P50 revision] Three Pilot Project awards related to AD, aging or neurodegeneration will also be issued each year. 3) Interact widely with researchers at UCSD, the VA Medical Center, and nearby research institutions (Salk Institute, Scripps Research Institute, Sanford-Burnham Institute, San Diego State University). 4) To collaborate with other AD Centers, NACC, and other national research efforts. The ADRC will follow about 500 subjects, using annual standardized evaluations that include the Uniform Data Set components. The ADRC will provide data to the National Alzheimer's Coordinating Center, and DNA to NCRAD. ADRC subjects will be offered participation in clinical trials organized by the Alzheimer's Disease Cooperative Study (ADCS) and by pharmaceutical companies, and participation in biomarker studies such as ADNI and PPMI. We will share subjects, data, brain images and biosamples with other researchers. 5) To continue to support innovative research, and to train new investigators 6) To foster professional education and training, improve public knowledge and awareness about aging and AD, and provide innovative support efforts for patients and families affected by AD.

Public health relevance
As part of an NIA-funded AD Centers Program that fosters research related to AD and non-AD dementias, which affect millions of Americans, the ADRC will provide an environment and core resources to enhance research, foster professional and community training, and coordinate interdisciplinary research. The revision of this P50 includes a new research Project to understand the pathogenesis of AD variants such as posterior cortical atrophy (PCA), characterized by young onset and AD neurodegeneration with preferential involvement of occipital and parietal cortices. The existence of neuronal genomic mosaicism (NGM) in sporadic Alzheimer's disease suggests a possible role for NGM in initiating pathology in affected brain regions of PCA, which may advance knowledge about the earliest pathological `seeds' of AD in general.